WUSTL Transdisciplinary Pre- and Postdoctoral Training Program in Obesity and Cardiovascular Disease

The complexities of biological, behavioral, social, and environmental risk factors for obesity and cardiovascular disease (CVD) necessitate team science, capable of crossing the boundaries of disciplinary-specific silos to conduct and evaluate research from a transdisciplinary approach to prevent and treat obesity and CVD across the lifespan. Efforts to facilitate greater collaboration among scientists trained across many fields and levels of training are not only valuable but also essential to solving such complex problems. Thus, we propose to continue an innovative, transdisciplinary pre- and postdoctoral training program in obesity and CVD at Washington University in St. Louis (WUSTL). WUSTL is an excellent research institution promoting transdisciplinary, translational research through its unique, collegial, scientific environment across campuses and departments. This program: 1) recruits and trains talented transdisciplinary pre- and postdoctoral trainees; 2) provides trainees with collaborative, transdisciplinary mentorship teams; and 3) provides training in the ethical and socially responsible conduct of obesity/CVD research. International authorities on obesity, Denise Wilfley, PhD (Director) and Samuel Klein, MD (Co-Director), lead the program, supported by highly- qualified, primary and co-mentors spanning 12 departments in the biomedical, cognitive and behavioral, and population health sciences. Our mentors are well-funded and have strong collaborative ties to facilitate the training of 4 pre- and 4 postdoctoral trainees each year. Combining pre- and postdoctoral trainees from diverse backgrounds (e.g., genetics, molecular cell biology, psychology, social work, public health, and neurosciences) has created and will continue to create a uniquely dynamic training environment. The WUSTL Nutrition Obesity Research Center, Institute of Clinical and Translational Sciences, Institute for Public Health, and Center for Diabetes Translation Research provide infrastructure and state-of-the-art resources to support trainees’ engagement in transformative, translational science. Program evaluations completed by trainees, program administration, and collaborative mentorship teams ensure trainees achieve short- and long-term indicators of productivity positioning them for success in obtaining academic positions and independent grants. Indeed, postdoctoral graduates of the program have been highly successful in obtaining academic positions and grant funding, and in the case of our predoctoral trainees, continuing their research training in prestigious positions. Not only is our training program innovative in its design but using a team science approach guided by stellar mentors, our trainees are prepared to create and contribute to transdisciplinary scientific approaches that are more likely to yield innovative solutions to the complex problems of obesity and CVD than research previously conducted by individual scientists within a single disciplinary field.

Public health relevance
Obesity is an area of critical public health concern, as it is associated with significant cardiovascular health risks and the onset of cardiovascular disease; as such, the National Institutes of Health has called for an acceleration of efforts to combat these problems from a multi-level, transdisciplinary perspective. In response to this significant public health priority, this training program, housed within Washington University in St. Louis, a world-class research institution with state-of-the-art resources, has recruited and will continue to recruit highly-qualified pre- and postdoctoral trainees across multiple disciplines and place them within transdisciplinary mentoring teams with faculty members who are leading researchers in the fields of obesity and cardiovascular disease prevention and treatment. These training experiences are producing young scientists equipped with the transdisciplinary research skills necessary to address the complex problems of obesity and cardiovascular disease prevention and treatment across the lifespan.